PEDIATRIC HEART TRANSPLANTATION--LONG TERM GROWTH AND NEURODEVELOPMENT

The goal of the study of Pediatric Heart Transplantation at Stanford is to learn about the growth and neurodevelopment of children who had cardiovascular surgery prior to their second birthday. Those infants who received a heart transplant are being compared with age and sex matched infants who underwent other major heart surgery in childhood. Extensive review of patient records was necessary to determine appropriate age and sex matched comparison subjects for this study.